A Randomized Trial of Chatbot for Prenatal Genetic Counseling

PROJECT SUMMARY
Current recommendations from the American College of Obstetricians and Gynecologists (ACOG) call for all
pregnant people to be offered screening and diagnostic testing options for aneuploidy and carrier screening for
cystic fibrosis and spinal muscular atrophy. As a result, the nearly 4 million pregnant people receiving prenatal
care in the United States annually require access to the associated, and complex, prenatal genetic counseling.
With these considerations and a commitment to person centered-care, informed decision-making is critical, and
predicated on people having adequate knowledge of the benefits and risks of different testing options. Obstetric
care providers have the challenge of addressing an ever-increasing number of topics during the first prenatal
care visit, and prenatal genetic counselors face a high number of referrals. Yet there is a national shortage of
genetic counselors with an uneven geographic distribution. The resulting lack of access to standardized prenatal
genetic counseling can lead to patient misinterpretation of the goals or results of prenatal genetic testing and
may be contributing to socioeconomic and racial disparities in prenatal genetic screening and diagnosis.
Language barriers further exacerbate misunderstanding of prenatal genetic testing options. Mobile digital tools,
including chatbots, provide an attractive alternative to in-person genetic counseling due to the near ubiquitous
availability of mobile devices among patients and ability to ensure tailoring and standardization. Previous digital
tools developed for prenatal genetic education showed promise, but most are instructional than interactive,
computer-based rather than mobile-based, and do not include information on carrier screening currently
recommended by ACOG. To address this critical need, a multidisciplinary team of perinatologists, genetic
counselors, and digital health experts developed an innovative, patient-informed, mobile chatbot (iPrenatal) to
simulate a text and audio-based counseling discussion about aneuploidy screening and diagnosis. Preliminary
data from our randomized trial of 258 English-speaking pregnant people showed significantly higher post-
intervention knowledge scores among patients who used iPrenatal compared with those who received routine
provider education. We now propose to leverage this success by engaging users in formative work to create
iPrenatal+ and provide all content in English and Spanish. We will evaluate iPrenatal+ in a randomized controlled
trial of 1,470 pregnant people in clinics serving racially and socioeconomically diverse pregnant women. Our
specific aims are: Utilize human centered design to transform iPrenatal to an enhanced digital educational
chatbot (iPrenatal+) for prenatal genetic counseling (Aim 1), Determine the effect of iPrenatal+ on patient
knowledge and uptake of prenatal genetic testing, compared to in-person genetic counseling (Aim 2), and Assess
ability of iPrenatal+ to narrow the gap in knowledge and uptake of prenatal genetic screening between English-
and Spanish-speaking patients, compared to in person genetic counseling (Aim 3).

Public health relevance
PROJECT NARRATIVE The proposed public health research will yield high-quality evidence on the ability of an educational chatbot to equitably increase patient knowledge and uptake of prenatal genetic screening and diagnostic tests. If shown to be effective, this validated chatbot interface for genetic counseling will be easily adaptable and scalable to other languages and clinical settings.